Sensory Adapted Dental Environments to Enhance Oral Care for Children

? DESCRIPTION (provided by applicant): This project, which builds upon our previous R34 NIDCR Planning and Feasibility study, is designed to examine the efficacy of a sensory adapted dental environment (SADE) to enhance children's oral care. Two groups will be studied: children with autism spectrum disorders (ASD) and typically developing (TD) children. Children with ASD, and a subset of TD children, exhibit sensory over-responsivity when confronted with experiential aspects of dental visits such as exposure to bright fluorescent lighting, touch in or around the mouth, or the texture and smell of various oral care products. This often results in increased anxiety and negative behavioral responses, which hinder the dentist's ability to perform treatment. In the proposed project, we test a SADE intervention designed to reduce children's anxiety and negative responses during oral care. The SADE intervention includes adaptations such as dimmed lighting, moving projections on the ceiling (fish, bubbles), exposure to soothing music, and application of a butterfly vest with wings that wrap around the child to provide calming sensations. The specific aims are to conduct a randomized clinical trial in order to: 1. Determine if SADE, relative to a regular dental environment (RDE), reduces physiological anxiety and negative responses (behavioral distress, perception of pain, sensory discomfort) during dental cleaning for children with ASD and TD children and test whether SADE's effect is greater for the ASD group. 2. Identify whether physiological anxiety mediates the beneficial effects of the intervention and whether severity of ASD and communication ability (ASD group), or dental anxiety, sensory over-responsivity, and age (both groups) act as moderating variables. 3. Assess the quality of care and cost effectiveness/savings of the dental cleaning associated with SADE. Research participants will be 220 ethnically diverse children aged 6-12 years, 110 with ASD and 110 TD. Using a randomized counterbalanced study design, each child will undergo two dental cleanings four months apart: one dental cleaning in RDE and one dental cleaning in SADE. This project is significant because it is the first full-scale trial of an intervention designed to reduce oral care problems in children with ASD. It is theoretically important because it will elucidate the mechanisms that underlie the effects of the SADE intervention and help to identify which subgroups of children, both TD and with ASD, which will benefit most from this approach. Based on the study findings, we will develop a model to transform the standard of pediatric dental care by modifying the sensory qualities of the dental environment; this model will have the potential to be utilized in dental clinics worldwide. As such the project promises to have a major public health impact insofar as the potential gains in oral health, child comfort, and cost-savings will be dramatic, potentially applying to more than one-fourth of all children.

Public health relevance
PUBLIC HEALTH RELEVANCE: Children with autism spectrum disorders (ASD), as well as many typically developing children, exhibit sensory over-responsivity in response to the bright lights, sounds, and touch at the dental office, making dental care challenging for such populations. In this study we will test an intervention that alters the sensory characteristics of he dental environment in order to decrease children's physiological anxiety and negative responses during oral care and contribute to increased child comfort as well as safer, more efficient, and less costly treatment. If successful, this intervention has the potential to revolutionize clinic-based dental care for the growing population of children with ASD, as well as for typically developing children with dental anxiety and/or sensory over-responsivity.